Mechanisms of compartmentalized signaling in electrically excitable cells

PROJECT SUMMARY
We often think of action potentials as a way for cells to quickly send signals over long distances and release
substances like neurotransmitters. This perspective overlooks the crucial role of electrical signals in triggering
intracellular biochemical processes, including gene expression. Our research has identified that endoplasmic
reticulum (ER)-plasma membrane (PM) junctions in the neuronal soma act as specialized sites for this electrical-
biochemical coupling. These ER-PM junctions are molecularly complex, exhibiting diverse architectures, protein
compositions, and distributions, indicating that they serve distinct cellular functions. Our lab's long-term goal is
to understand how electrical signals are translated into specific biochemical responses, such as activating gene
expression programs. We propose that ER-PM junctions are central to translating membrane depolarizations
into intracellular signaling events, and our work is focused on discovering the mechanisms underlying their
assembly and function. Building on our previous work in defining the proteome and physiological roles of these
junctions in mammalian neurons, our five-year goal is to investigate the regulatory mechanisms governing their
organization, with a particular emphasis on cAMP-dependent protein kinase (PKA) signaling. First, we aim to
define the signaling interactions at PKA-containing ER-PM junctions, focusing on how distinct A-kinase
anchoring proteins (AKAPs) recruit additional scaffolding proteins and shape the composition of these signaling
complexes. We will use genetic and biochemical approaches to map enzyme substrates targeted to these sites
and identify how these enzymes influence somatic signaling pathways. Secondly, we will examine how AKAP-
enzyme signaling complexes are structurally organized, especially how conserved, disease-linked domains
within AKAPs direct the formation of specific complexes at ER-PM junctions. A key aspect of our research will
be to determine how PKA’s kinase activity versus its role in organizing ER-PM junctions affects signaling
outcomes. By identifying the molecular components and pathways involved, this research aims to clarify the
roles of ER-PM junctions in neurons and uncover principles applicable to similar structures in other cell types.
Such knowledge will improve our understanding of how electrically excitable cells fine-tune their signaling
systems to regulate processes like gene expression.

Public health relevance
PROJECT NARRATIVE Many cells in our body must convert electrical signals into biochemical responses to maintain proper function. We discovered that endoplasmic reticulum-plasma membrane junctions are specialized domains that coordinate this electrical-biochemical coupling in brain neurons. Our goal is to uncover the molecular mechanisms governing the organization and function of these domains and how their disruption contributes to disease.